THE EFFECTS OF GROWTH HORMONE ON BONE MINERAL METABOLISM

To demonstrate that the discontinuation of growth hormone after cessation of pubertal growth in children with growth hormone deficiency is associated with high-turnover osteopenia. To demonstrate that growth hormone administration to growth hormone deficient children selectively increases osteoblastic activity.